Diminished Motor Performance in Athletes Cleared to Return to Play after Sports-Related Concussion

PROJECT SUMMARY/ABSTRACT
Sports-related concussion, a type of mild traumatic brain injury (TBI), is a significant public health concern,
especially given recent discoveries that athletes with a history of concussion are more likely to sustain new
injuries when they return to high-risk activity, which is linked to adverse long-term health outcomes.
Importantly, this heightened risk of new injury has been found in young athletes who were “cleared” to return to
play using current clinical evaluation protocols, suggesting that these protocols are suboptimal. An option for
improved evaluation is dual task assessment – appraisal of motor performance with a secondary task added,
typically a cognitive distractor task. Notably, dual task assessments have elicited diminished motor abilities in
young athletes who were “cleared” to return to play after concussion. These diminished motor abilities may
underlie the increased likelihood for new injury, however, it is currently unclear why clinical evaluation protocols
fail to detect them. Therefore, as a logical first step, the objective of the current proposal is to better understand
why diminished motor abilities are missed with clinical evaluation protocols. Preliminary neuroimaging data and
dual task performance data suggest that “cleared” youth with a history of concussion compensate for
diminished motor ability by recruiting additional neural attention resources to support single task performance,
or motor performance without a cognitive distractor task. Conceivably, this compensatory recruitment is
insufficient for dual task performance, which is why dual task assessments elicit diminished motor abilities.
Current clinical evaluation protocols include subjective symptom reporting and behavioral assessments
administered in a single task design (i.e. without secondary task distraction). However, nearly all sports require
motor performance in the presence of distraction. This proposal includes behavioral measures with improved
ecological validity (i.e. dual task assessments) and seeks to elucidate neural underpinnings of diminished
motor abilities in “cleared” young athletes with recent concussion. Neuroimaging methods include a well-
established electroencephalography (EEG) paradigm and an innovative technique – a functional near-infrared
spectroscopy (fNIRS) system that can accommodate gross motor movement. “Cleared” young athletes with
recent concussion will be compared to never-concussed young athletes and evaluated on single and dual task
performance with simultaneous neural recording. It is anticipated that these “cleared” young athletes will show
comparable single task performance but – importantly – have poorer dual task performance and demonstrate
aberrant recruitment of neural attention regions compared to never-concussed peers. These findings would
suggest that some “cleared” athletes have not completely recovered from their concussion. By identifying
neural characteristics associated with diminished motor abilities and increased risk for new injury, this work will
have a significant impact by: 1) better describing the neurophysiology of concussion and 2) laying the
foundation for future studies designed to identify and reduce short- and long-term risk of concussion.

Public health relevance
PROJECT NARRATIVE Athletes with a history sport-related concussion have increased vulnerability to repeat concussions when they return to high-risk activity, and repeat concussions are linked to adverse long-term health outcomes. Importantly, this has been found in athletes who were deemed ready (i.e. “cleared”) to return to play. Here, we evaluate “cleared” athletes with recent concussion using innovative neuroimaging and behavioral techniques with the goal of identifying neural mechanisms that may explain this increased vulnerability to repeat injury.